Western Neurotrauma Symposium 2024

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide. However, due to its complexity, it remains one of the most challenging neurological conditions to treat. Advances in our understanding of TBI pathobiology and improvements in clinical care for TBI require multidisciplinary exchange of scientific ideas and encouragement of promising young investigators in the field. Our first Western Neurotrauma Symposium (WNTS) was well received and especially noted for the attention given to the trainees and early investigators and the collaborative environment. The WNTS will continue to be a unique regional conference providing an annual venue for a broad range of neurotraumatology research, with a focus on trainees and early career investigators, presentation of cutting-edge data in a safe environment, multidisciplinary collaborative ideas and a more intimate setting to allow direct interactions between attendees. This meeting will be instrumental in developing the next generation of investigators and ideas, without duplicating or replacing opportunities provided at existing National and International Neurotrauma Symposia. While the focus of continued WNTS funding would be development of regional young investigators and collaborators, attendance at the meeting would be open. The first WNTS showed participation of a more diverse population from centers throughout the Western U.S. with specific outreach and travel awards to encourage active participation of underrepresented groups in neuroscience/neurotrauma research. In 2022, the R13 supported 17 young investigators and trainees, and faculty. In 2023 19 were supported, enhancing diversity at all levels. The additional support provided by renewing this grant for 2024 would specifically enable expanded inclusion of investigators from outside of the UC, bringing in research and clinical trainees and faculty from across the western states, for whom travel, expense and time constraints may limit opportunities for young persons to attend national or international conferences.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide, and one of the most challenging neurological conditions to treat due to its complexity. A multidisciplinary exchange of scientific ideas between trainees and investigators at all levels is therefore necessary to continue advancing our understanding of TBI, and to improve clinical care and public health outcomes. The Western Neurotrauma Symposium (WNTS) provided a forum for scientists and clinicians from across the western United States to spotlight our trainees and early investigators and has already initiated collaborations sharing data; and will continue to expand diversity and inclusivity in our field, generate new ideas and develop future research grant opportunities.